Mortality from Chronic Illnesses in Poultry and Non-Poultry Workers - Resubmission

PROJECT SUMMARY/ABSTRACT
Workers in poultry-slaughtering and -processing plants have one of the highest human exposures to many microbial
and chemical agents that can cause diseases in chickens (e.g., avian leukosis/sarcoma and reticuloendothelosis
viruses, which can cause cancer; Mareks's disease virus, which can cause atherosclerosis). These poultry
transmissible agents can infect humans and might increase the risks for cancer and nonmalignant diseases. Poultry
workers are also exposed to many chemicals—e.g. polycyclic aromatic hydrocarbons (PAH), benzene, and
phthalates—which may play a role in the occurrence of chronic diseases in these workers.
We have been studying mortality among these workers for many years, and have found they have an elevated risk for
non-malignant (e.g. cardiovascular, diabetes mellitus), neurological, and malignant chronic diseases. These risks were
based on small numbers of causes of death. In 2011, we conducted a large case- cohort study nested within a cohort
of 30,411 poultry workers and 16,405 non- poultry workers identified from rosters of the United Food & Commercial
Workers (UFCW) unions in Baltimore, MD and Marshall, MO, and the UFCW Chicago Union Pension Fund. The
Baltimore cohort has been followed up from 1950 through 2010, the Marshall cohort from 1969 through 2010, and the
Chicago cohort from 1972 through 2010. During these periods, a total of 12,638 deaths from all causes occurred in the
combined group of 46,816 poultry and non-poultry workers. Cases in the case-cohort study were defined as all deaths
from 7 cancer sites (lung, liver, pancreas, brain, blood, buccal, and ovary) observed to occur in excess in the poultry
workers through 2010. In 2019, we secured funding to study the correlation of working for poultry plants and cervical,
esophageal, and colon cancers. To identify new deaths in our three cohorts we obtained mortality files from the
National Death Index, which revealed that we can add 4,164 new deaths to 12,638 deaths, bringing the new total to
16,802 deaths. In the proposed study, our expected outputs and outcomes are to add the new cause-specific
mortalities that occurred in these cohorts to confirm previous findings, and examine with greater statistical power the
relation of poultry and non-poultry workplaces with causes of death from malignant and non-malignant diseases.
Demonstration of these risks will lead to steps being taken to implement measures to protect not only these
workers, but also the general population. This will contribute to the NIOSH strategic goal to reduce
occupational cancer, cardiovascular disease, adverse reproductive outcomes, and other chronic diseases. The
proposed research falls under the National Occupational Research Agenda (NORA) Sector Agenda for
Manufacturing, and Cross-Sector Agenda for Cancer, Reproductive, Cardiovascular and Other Chronic
Disease Prevention (CRC). The proposed research also contributes to the NIOSH Research to Practice (r2p)
initiative by serving as a partner in identifying occupational safety and health issues and needs, and
demonstrating the impact of these efforts on improving the safety and health of workers.

Public health relevance
PROJECT NARRATIVE In our previous studies, we observed that deaths from chronic disease such as cancer, cardiovascular diseases, neurologic and psychiatric conditions (e.g. Alzheimer's disease, schizophrenia, Lou Gehrig's disease) were occurring in excess among poultry workers who are exposed to a plethora of microbial and chemical agents, which increase their risks for chronic diseases: non- malignant and malignant illnesses. These initial observations were based on small numbers of deaths in some instances; here, we propose to analyze existing data that has been accumulated since the early studies. This analysis will identify new conditions that may be occurring in excess in poultry workers, as well as workers in other industries who have never been studied before and belong to the same unions as the poultry workers.